Deciphering Macrophage Phenotype and Function in Disc Herniation and associated Back/leg Pain

Project Summary
Intervertebral disc herniation is a major cause of back/leg pain, which affects 80% of people with an estimated
annual cost of $100 billion in the U.S. alone. Treatment options for disc herniation and its associated pain are
very limited, largely due to insufficient understanding of pathological processes. Current research indicates that
inflammation is a key contributor to back/leg pain after disc herniation in both acute and chronic phases. Others
and we have found that macrophages are the predominant infiltrated cells at disc hernia sites. Macrophages
may play distinct roles in various phases of disc herniation with tissue- and disease stage-specific phenotypes
due to their remarkable plasticity and sensitivity in response to microenvironment cues. Our preliminary data
revealed a mixed population of macrophages infiltrated at disc hernia sites and transiently depletion of
macrophages reduced local inflammation. However, our knowledge of dynamic phenotypes and functions of
infiltrated macrophages in disc herniation remains scarce. Our central hypothesis is that specific
subpopulations of macrophages contribute to the progression of disc herniation at different stages and that
modulation of macrophages will alleviate inflammation-induced pain and restore disc homeostasis. Our
objective of this R01 is to better characterizing macrophage phenotypes, functions, and macrophage-disc
crosstalk in disc herniation and pain at a mechanistic level, which facilitates our long-term goal to develop
disease-modifying therapies for disc herniation and associated back/leg pain. Successful completion of this
project will significantly advance our understanding of macrophage functions in disc herniation and lay a solid
foundation for future therapeutic development, such as a selectively macrophage-targeted immunomodulation
strategy.

Public health relevance
Project Narrative The proposed research is relevant to public health as it explores phenotypes and functions of macrophages in disease progression of intervertebral disc herniation and back/leg pain that are fundamental for the development of effective treatment. Such findings are relevant to the part of NIH’s mission that pertains to developing fundamental knowledge that will help to protect and improve health.